Computationally modeling individual differences in probabilistic decision-making across positive and negative valence domains

PROJECT SUMMARY
In our daily lives, we choose between different courses of action with the hope of achieving desired positive
outcomes and avoiding feared negative outcomes; this is complicated by various forms of uncertainty that impact
the probability that any given action will result in a particular outcome. Within NIMH’s RDoC framework, studies
of the mechanisms involved in reward-based action valuation and choice have informed constructs listed under
the Positive Valence Systems (PVS) domain. Associated paradigms examine how differences in outcome
probability (first order uncertainty) and action-outcome contingency uncertainty (second order uncertainty)
impact choice between alternate options. Within the Negative Valence Systems (NVS) domain, the construct of
potential threat (anxiety) does not include consideration of the impact of potential threat, its probability and action-
outcome contingency uncertainty, upon action valuation or choice; in addition paradigms listed under the NVS
domain have no choice (instrumental) element and use physiological indices as dependent measures. These
differences between constructs and tasks across the PVS and NVS domains hinder attempts to elucidate
whether psychopathology-related deficits in probabilistic decision-making and the factors influencing action
valuation and choice are common across both domains or unique to one or the other. Here, we will address this
by creating equivalent PVs (reward) and NVS (shock) versions of two probabilistic decision-making tasks. We
will use a hierarchical Bayesian computational framework to model behavioral and brain (functional magnetic
resonance imaging) data from PVS and NVS versions of each task. This data will be acquired from healthy adult
humans with a range of anxiety and depressive symptomatology. In addition to group-level analyses, we will use
bifactor analysis to examine the latent factors underlying variance in anxiety and depressive symptomatology
across participants and will relate scores on these factors to parameter estimates obtained by modeling of
behavioral and brain data. Using this approach, we will examine commonalities and differences in the
mechanisms supporting probabilistic decision-making when potential outcomes are aversive versus rewarding
and alterations to these mechanisms as a function of anxiety and depressive related symptomatology. We hope
that this will advance our understanding of the aspects of decision-making disrupted in anxiety and depression
and the potential consequences for daily life. An additional goal of this research is to provide tasks and models
that can be used in future clinical studies of probabilistic decision-making across both PVS and NVS domains.

Public health relevance
Project Narrative In our daily lives, we make decisions as to how best to achieve desired positive outcomes and to avoid feared negative outcomes; this is complicated by various forms of uncertainty that impact the probability that any given action will result in a particular outcome. Our understanding of the computations and brain circuitry involved in probabilistic decision-making, and disruption of these mechanisms in anxiety and depression, has been limited by lack of parallel studies using positive (rewarding) and negative (aversive) outcomes. The work proposed here examines commonalities and differences in the computations and brain mechanisms supporting human probabilistic decision-making when potential outcomes are aversive versus rewarding, investigates alterations to these computations and their neural implementation as a function of anxiety and depressive symptomatology, and provides tasks and models that can be used in future clinical studies.